Developmental origins and homeostatic mechanisms underlying adult phenotypes

PROJECT SUMMARY
Mechanisms underlying the origin and maintenance of adult form, and naturally occurring variation in adult
form, remain poorly understood. This research program seeks to elucidate how gene activities are translated
through cellular behaviors into speciﬁc morphological outcomes at adult stages. Such information will con-
tribute to understanding patterning and morphogenetic mechanisms essential for postembryonic development,
with relevance to human genetic disease, birth defects, aging and regenerative medicine. For these efforts, the
work uses pigmentation of zebraﬁsh, its close relatives in the genus Danio, and more distantly related teleost
ﬁshes. Pigment cells in these animals and other vertebrates arise from embryonic neural crest cells that also
contribute to a wide variety of other tissues and organs, including most of the peripheral nervous system and
craniofacial skeleton. Defects in neural crest derived lineages generally, and pigment cells speciﬁcally, are as-
sociated with numerous hereditary pathologies as well as cancers, including melanoma. During normal devel-
opment, pigment cells that arise either directly from neural crest cells or indirectly through postembryonic stem
cell intermediates organize into highly stereotyped, largely two dimensional patterns in the transparent skin.
Cell behaviors during pattern formation are readily observed as phenotypes develop, and genetic mechanisms
are accessible through mutational analyses and other approaches, both in striped zebraﬁsh and in other
species having very different adult patterns. The work described here builds on prior effort in this program, and
takes an unusually integrative approach to understand pattern and pattern variation, combining manipulative
experiments, genetic analysis, high resolution imaging, cutting edge genomics, comparative biology and be-
havioral assays. Goals in the coming years are to elucidate: (i) mechanisms by which pigment cell progenitors
are speciﬁed for different pigment cell types during development, and how diversiﬁcation of cell types has been
achieved evolutionarily; (ii) genetic and cellular mechanisms underlying self-organizing interactions among
pigment cells that are essential for pattern formation, and how these interactions and permissive factors have
changed to generate alternative pattern states among species; (iii) the roles of positional information in the tis-
sue environment in setting the location of discrete pattern elements that are essential for establishing pattern,
and how such information contributes to qualitatively different types of pattern across species. These efforts
will provide novel insights into pattern development and cell type diversiﬁcation over both developmental and
evolutionary time. General principles uncovered will likely be applicable to a wide range of traits that depend to
varying degrees cell type diversiﬁcation, self-organizing cellular interactions, and positional information derived
from tissue environments.
1

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health as it focuses on fundamental aspects of vertebrate devel- opment—including cell-type diversiﬁcation, self-organizing interactions and positional information—that have implications for normal patterning and homeostasis, genetic disease and birth defects, and the goals of replac- ing or repairing lost tissue through regenerative medicine. 1